Community Outreach and Engagement

PROJECT SUMMARY/ABSTRACT
The National Cancer Institute (NCI)-designated University of Kentucky (UK) Markey Cancer Center (MCC)
defines its catchment area as the Commonwealth of Kentucky, with a special focus on the underserved
communities of Appalachian Kentucky. There is no greater need for a Comprehensive NCI Cancer Center than
in Kentucky, which is recognized for the highest overall cancer incidence and mortality rates in the United
States, significantly elevated rates of cancer risk factors such as tobacco use and obesity, and severe
socioeconomic disparities. The MCC has been at the forefront of combatting cancer and its related disparities
in Kentucky for over 40 years through innovative cancer research, clinical care, and community outreach. Led
by Dr. Robin Vanderpool (CP), Director of MCC Community Outreach and Engagement, MCC’s community
outreach and engagement infrastructure includes: the MCC Network, consisting of the MCC Research Network
(MCCRN, 6 community sites) and MCC Affiliate Network (MCCAN, 18 community hospitals); the developing
Behavioral and Community-Based Research Shared Resource Facility (BCBR SRF); the Kentucky Cancer
Registry; multiple cancer center and state outreach programs; well-aligned MCC cancer research projects;
UK’s rurally placed health care, professional education, and community resources; and other vested local,
state, national, and international stakeholders. Utilizing this unique infrastructure and diverse network of
partners as well as data- and context-driven approaches to working with communities, MCC has an extensive
portfolio of innovative and impactful projects focused on effective cancer control practices and health policy
recommendations that have reached thousands of Kentucky residents and health care professionals. With
continued CCSG funding, the MCC is well positioned to use this remarkable and expanding infrastructure to
impact cancer within and beyond Kentucky and respond to emerging public health issues. The MCC’s
overarching goal for community outreach and engagement is to accelerate science-to-practice translation
across the cancer care continuum by leveraging and expanding its outreach and engagement infrastructure
and network of partners within and beyond the Commonwealth of Kentucky. Specific Aims are: (1) to enhance
the MCC’s ability to define and characterize its catchment area using cancer surveillance data, cancer registry
and health insurance data linkages, and locally derived population health assessment data; (2) to increase
dissemination and implementation of evidence-based clinical practices and cancer control programming within
and beyond MCC’s catchment area; and (3) to enrich bidirectional relationships and structures for conducting
community outreach and engagement within and beyond MCC’s catchment area. In achieving these aims,
MCC is solidly positioned to enhance and expand its existing community outreach and engagement initiatives
over the next 5-year CCSG funding period to further reduce Kentucky’s significant cancer burden and improve
quality of life among all Kentuckians.